From the Scanner to the Clinic: Patient Oriented Research and Mentorship

The overall aim of this K24 Mid-Career Investigator Award in Patient-Oriented Research entitled “From
the Scanner to the Clinic: Patient Oriented Research and Mentorship” is to allow me (Diana Martinez,
MD) to continue to expand my programmatic line of clinical research and mentoring in substance use
disorders (SUD). My work has previously on using Positron Emission Tomography (PET) to identify
neurotransmitter systems for medication development in SUD. More recently, I have moved into more
clinically oriented research studies, including a clinical trial and a study investigating transcranial
magnetic stimulation as a treatment in addiction. This is an exciting new direction in my research career.
Recent changes to my career also include a greater role as a mentor. As a psychiatrist who has
dedicated her career to neuroscience research, I am in a unique position to provide advice and guidance
to clinically trained physicians pursuing careers in research. This K24 will support my current work with
mentees and will help me to develop new mentorship opportunities.
The Mentoring Plan emphasizes efforts with post-doctoral trainees (psychiatric fellows and residents)
and continuation of efforts with trainees at various levels of development: pre-doctoral trainees (medical
students), and junior faculty. This award would provide support towards my goal of training of future
clinical investigators.

Public health relevance
This K24 Midcareer Investigator Award in Patient-Oriented Research will enable Dr. Diana Martinez to advance her skills in clinical research and provide mentorship to clinical researchers, including fellows in addiction psychiatry and medical students. This K24 proposes a focused interdisciplinary program for Dr. Martinez and a comprehensive plan for mentoring clinician investigators.